Investigating macrophage-to-tumor mitochondrial transfer

Project Summary
Tumor metastasis is the leading cause of cancer related mortalities, yet preventing this malignant phenotype
continues to elude scientific investigators. In efforts to understand what factors promote malignant cancer
behavior, the tumor microenvironment has become an intense focus of study and tumor-infiltrating macrophages
have been shown to contribute to poor prognosis. We aimed to better understand how macrophage-tumor cell
interactions promote aggressive tumor phenotypes. In this effort, we demonstrated that macrophages transfer
bulk cytoplasmic material directly to tumor cells and that recipient cells exhibit enhanced migration in vitro and
dissemination in vivo. Recently, we set out to determine what material is transferred during these interactions.
Using primary human macrophages and human breast cancer cells, we observed that macrophages transfer
mitochondria to breast cancer cells. Importantly, cancer cells that received macrophage mitochondria also
exhibited enhanced cell proliferation, a critical step of the metastatic cascade. We then aimed to determine
whether macrophage polarization influenced mitochondrial transfer and observed that pro-tumorigenic M2-like
macrophages exhibit enhanced rates of mitochondrial transfer. Since Notch signaling has been shown to
influence macrophage polarization, we set out to determine whether Notch signaling also influences the transfer
of mitochondria and found that the inhibition of Notch signaling resulted in increased rates of macrophage
mitochondrial transfer and promoted M2-like macrophage phenotypes. These findings have set forth the
proposed investigation of macrophage-to-tumor mitochondrial transfer. By utilizing in vitro and in vivo models we
will investigate mitochondrial transfer from primary mouse pro-tumorigenic Tumor Associated Macrophages and
determine how their mitochondrial dynamics influence mitochondrial transfer. Furthermore, we will determine
how Notch signaling influences these processes and subsequent mitochondrial transfer. Given that Notch
signaling inhibitors are currently under clinical pursuit for the treatment of breast cancer, these data present an
enticing premise: if inhibition of Notch signaling promotes mitochondrial transfer and subsequent tumor
proliferation, what basic biology may be overlooked in the context of this treatment? In this proposal we will shift
the focus from post-transfer tumor cell phenotypes to pre-transfer macrophage biology and how these
phenotypes may be influencing mitochondrial transfer. Importantly, the proposed focus on pre-transfer biology
of the mitochondrial ‘donor’ cell and what dynamic properties promote mitochondrial transfer have not been
investigated. Our work will illuminate a currently unappreciated mechanism of macrophage-associated
tumorigenicity. By providing insights to how foundational macrophage biology and Notch signaling influence
macrophage-to-tumor mitochondrial transfer, this work will help guide clinical efforts of Notch inhibition and prime
future investigations of macrophage-tumor interactions to prevent mitochondrial transfer and hinder the
metastatic cascade.

Public health relevance
Project Narrative Although tumor metastasis is the primary cause for cancer-related deaths, preventing the malignant spread of the disease continues to elude researchers and oncologists a like. It has come to be appreciated that macrophages, a member of the innate immune system, can interact with tumor cells to promote their aggressive behavior. In this study we will focus on what macrophage biology precedes these interactions to develop a robust understanding of how our immune system contributes to disease progression.